Cognitive Aging Trajectories in Survivors of Trauma

Dementia and the prodromal stages of cognitive decline, together, affect approximately 25-30% of older adults
across the United States (U.S.). Posttraumatic Stress Disorder (PTSD) has been linked to a 111% increased
risk of developing dementia of any type, even after controlling for potential confounders such as traumatic brain
injury (TBI). Therefore, PTSD may be an important target for early prevention of cognitive decline and potential
progression to dementia. Most studies on PTSD and cognition have used a cross-sectional study design and
have not examined important potential effect modifiers (e.g., sex and APOE4 carrier status), leaving a gap in
our fundamental understanding of the effect of PTSD on longitudinal trajectories of cognitive functioning.
Further, although PTSD is more prevalent in women, most research on PTSD and cognition has been
conducted in men. This proposal is of timely public health importance, as the pre-pandemic lifetime prevalence
of PTSD in the U.S. was 6%, but post-pandemic epidemiological findings have indicated a rise to
approximately 32% among young adults. COVID-19 events have also resulted in PTSD symptoms without
meeting Diagnostics and Statistical Manual of Mental Disorders, 5th edition (DSM-5) Criterion A. Therefore,
critical research gaps in our understanding of the effect of PTSD on cognitive aging include: 1) prospective
investigation wherein temporal sequencing and rate of cognitive decline can be evaluated in the context of
PTSD, 2) testing the potential modifying effects of sex and APOE4 carrier status on the relationship between
PTSD status and cognitive decline and, 3) understanding whether Criterion A is necessary when determining
the relationship between PTSD and cognitive decline. Aims 1 and 2 will leverage existing data from the
National Alzheimer's Coordinating Center (NACC). In adults aged 55+ years, multilevel modeling and
interaction analyses will determine the impact of PTSD status on trajectories, rate, and temporal sequence of
domain-specific cognitive decline and will test sex and APOE4 carrier status as potential effect modifiers. For
Aim 3, men and women participants, aged 65+, with and without Criterion A trauma, will be recruited and
multiple regression will be used to unambiguously clarify if PTSD severity (Criteria B through E) is associated
with cognitive functioning without meeting Criterion A. This K01 award will provide training and mentorship in
aging health, cognitive aging, sex-specific health effects of PTSD, neuropsychology of PTSD, longitudinal
study design, and advanced statistics and propel the PI to become an independent investigator with expertise
in the effects of traumatic stress and biopsychosocial factors on cognitive aging, with a sex-specific focus and
in alignment with Goals B-3, B-4, and F-4 of NIA’s Strategic Directions 2020-2025.

Public health relevance
PROJECT NARRATIVE PTSD prevalence is high and PTSD increases the risk of dementia. The proposed research will: a) investigate the impact of PTSD on the rate of domain-specific cognitive decline, b) test potential effect modifiers, including sex, of the relationship between PTSD and rate of cognitive decline, and c) determine the association between cognitive functioning and PTSD severity with and without Criterion A trauma. Successful completion of this project has important public health implications including indicating whether PTSD should be considered a target for the early prevention of cognitive decline that may lead to dementia and increasing understanding of sex differences in the relationship between PTSD and cognitive decline.